Advancing Suffolk County's Conformance with the VNRFRPS

PROJECT SUMMARY/ABSTRACT The objective of our project is to advance Suffolk County's conformance with the Voluntary National Retail Food Regulatory Program Standards. Over the course of five years we will implement a strategic plan to increase our conformance with the standards. Our project includes updating our food code based on the current FDA Model Food Code, increasing active managerial control through Chinese and Spanish translations of our Food Manager's Course, updating our computerized food inspection program to track risk factors, updating our computerized food database to include the capability of sending email notifications to food service establishments, implementing hand washing demonstrations in our Food Manager's Class and preparing Go Packs for conducting food service inspections during an emergency. Technological improvements include a computerized test scoring system, a scanner for food service establishment floor plans and tablets for conducting food service inspections. Increased conformance with the national standards will contribute to a decrease in risk factors that contribute to food borne illness, reduced rates of foodborne illness at our regulated food service establishments and contribute to a nationally integrated food safety system.

Public health relevance
Public Health Relevance Statement The objective of our project is to advance Suffolk County's conformance with the Voluntary National Retail Food Regulatory Program Standards. Increased conformance with the national standards will result in an increase in active managerial control, a decrease in the occurrence of risk factors that contribute to foodborne illness, reduced rates of foodborne illness at regulated food service establishments in Suffolk County and contribute to a more integrated national food safety system. __SpecificAimsTextDelimiter__ Specific Aims The objective of our project is to advance Suffolk County's conformance with the Voluntary National Retail Food Regulatory Program Standards (VNRFRPS). The goals of our project include translation of the Food Manager's Class into Spanish and Chinese, adopting a new Suffolk County Food Sanitary Code based on the current FDA Model Food Code, upgrading our computerized food inspection program with the updated Food Code and the ability to track risk factors, implement electronic grading of Food Manager's tests, Completing a Risk Factor Study, installing hand washing sinks in our Food Manager's classroom, upgrading our computerized food database with the capability of sending email notifications to food service operators, scanning all food establishment plans, compiling 20 Go Packs, a 10% decrease in the occurrence of risk factors, completing audit of Program Standards, developing a quality assurance program, completing Standards 1, 3, 4 and 9 of the VNRFRPS . The anticipated outcomes of the project are an increase in active managerial control, a decrease in the occurrence of risk factors that contribute to foodborne illness, reduced rates of foodborne illness at regulated food service establishments in Suffolk County and a more integrated national food safety system.